Mechanisms of Sympathetic Overactivity in Post-traumatic Stress Disorder

Post-traumatic stress disorder (PTSD) is a highly prevalent and debilitating mental health
disorder that is independently associated with an increased risk of cardiovascular (CV) disease
and hypertension. Given the large numbers of post-9/11 Veterans afflicted with PTSD,
addressing this under-recognized but highly significant consequence of PTSD is of paramount
importance to protect the future health of these young Veterans. We have shown that
post-9/11 Veterans with PTSD have overactivation of the sympathetic nervous system (SNS)
during mental stress and impaired arterial baroreflex sensitivity (BRS) that could contribute to
the pathogenesis of hypertension and CV disease in these patients. While we have now
established that central sympathetic output is augmented in PTSD, the downstream effects of
SNS output on blood pressure (BP) regulation in PTSD remain unknown and is a major goal of
this proposal. We hypothesize that augmented sympathetic nerve activity in PTSD leads to
augmented SNS-mediated vasoconstriction within the kidney, an organ with a critical role in BP
regulation. Exaggerated increases in sympathetically mediated renal vasoconstriction could
perpetuate sustained increases in BP over time via renal sodium reabsorption and activation of
the renin-angiotensin system (RAS). To test this hypothesis, we will measure renal blood flow
velocity using Doppler ultrasound, continuous hemodynamics, muscle sympathetic nerve
activity (MSNA) using microneurography, plasma renin activity and inflammatory biomarkers at
rest and during mental stress in post 9/11 Veterans and matched controls. We further
hypothesize that SNS activation leads to an exaggerated vasoconstrictive response (i.e.
heightened neurovascular transduction of SNS activity) mediated by abnormal vascular
adrenergic receptor sensitivity in PTSD. To test this hypothesis, we will determine vascular
alpha-1 adrenergic receptor (α1AR) sensitivity by measuring vasoconstriction in response to
exponentially increasing doses of the selective α1AR agonist phenylephrine using a linear
variable differential transformer in PTSD and controls. Finally, prior studies have shown that
transcutaneous vagus nerve stimulation (tVNS) reduces SNS activity, improves BRS, and
lowers inflammation in healthy humans and a number of chronic diseases; however, the
potential benefits of tVNS on SNS function and regulation in PTSD have never previously been
investigated. We hypothesize that tVNS acutely lowers SNS activity and improves sympathetic
and cardiovagal BRS in PTSD. To test this hypothesis, we will measure MSNA, EKG,
hemodynamics, inflammation, and BRS using pharmacologic manipulation of BP at rest and
during tVNS (versus sham stimulation) in PTSD patients. tVNS could be a novel
nonpharmacologic approach to reducing SNS activity and restoring BRS in these patients.
Improving SNS overactivity and BRS may have long term benefits on reducing CV risk in PTSD
patients.

Public health relevance
Post-traumatic stress disorder (PTSD) is a debilitating and highly prevalent disorder in both the Veteran and general population. One under-studied, but highly significant consequence of PTSD is a significantly increased risk of developing hypertension and cardiovascular disease. The overarching goal of this research program is to elucidate the mechanistic roles of sympathetic nervous system (SNS) dysregulation in future cardiovascular risk in post-9/11 Veterans with PTSD. Specifically, this project will determine the downstream effects of heightened SNS reactivity on renal vasoconstriction and neurovascular transduction mediated by vascular alpha-1 adrenergic receptor sensitivity using state-of-the-art human physiology techniques. We will also assess the potential therapeutic role of transcutaneous vagus nerve stimulation in ameliorating SNS overactivation and improving arterial baroreflex sensitivity in PTSD. Given the large numbers of post-9/11 afflicted with PTSD, understanding the mechanisms of SNS overactivity in PTSD is crucial for impacting future cardiovascular risk.